Project 1: Human and Non-human Primate Influenza B-cell Repertoires

Abstract -- Project 1
Project 1 will study the updating of imprinted responses to influenza infection and vaccination that occurs
during subsequent influenza vaccination. The hypothesis is that imprinting of B cell memory to influenza by
initial infection will induce more neutralization but less breadth directed at heterologous strains, while initial
imprinting by influenza vaccine will provide greater breadth but less neutralizing activity. Project 1 will test
this hypothesis in a series of experiments in humans and rhesus macaques, in which we will probe the
B cell repertoires in response to combinations of influenza infection and vaccination. Project 1 will perform
experiments in non-human primates where the exposure to influenza antigens can be tighly controlled and
will collect samples from humans of all ages receiving influenza vaccination to quantify responses in a “real
world” setting. For all aims, the goals will be to 1) quantify the effect of exposure to different influenza
subtypes by infection and vaccination, 2) quantify recall upon antigenic challenge by vaccination or infection
and 3) quantify the epitope specific response to influenza. We will pursue these golas using serology,
Nojima cultures, and monoclonal antibody (mAb) isolation, for epitope mapping and structural studies, in
collaboration with Project 4.